Development of a Novel Immunotherapy Platform for Triple-Negative Breast Cancer

Triple-negative breast cancer (TNBC) accounts for 15-20% of all breast cancer diagnoses, is the most
aggressive form of the disease, and has the poorest clinical outcome. Chemotherapy is the mainstay treatment
for these patients despite significant treatment-related toxicities and short-term clinical responses. Therefore,
the need for more effective and better tolerated treatment modalities for TNBC is warranted. Immune checkpoint
blockade (ICB) is an immunotherapy-based approach that can reinvigorate durable immunity in advanced
cancers such as melanoma and lung. In the case of other cancer types, such as breast cancer, the FDA approved
the first immunotherapy for TNBC in March 2019. This regimen consists of α-PD-L1 antibody (Tecentriq) plus
Abraxane (Nab-paclitaxel) as a frontline therapy for patients with unresectable locally advanced or metastatic
PD-L1+ TNBC. Unfortunately, overall response rates remain relatively low and survival outcomes are extended
for only a few months due in large part to expansion of immunosuppressive polymorphonuclear myeloid-derived
suppressor cells (PMN-MDSCs) that potently suppress antitumor immunity. Thus, developing strategies to
reduce PMN-MDSC activity may improve response rates to α-PD-L1/Abraxane in TNBC. One approach to lessen
myeloid-based mechanisms of immune suppression is by modulating signaling pathways that govern immune
suppression to those that promote stimulation in a concept known as reprogramming. Toll-like receptor (TLR) 5
signaling can both mitigate MDSC activity and stimulate antitumor immunity against multiple pre-clinical tumor
models, including PD-L1+ TNBC. Thus, we posit that TLR5 agonists are a novel class of agents that can mediate
myeloid reprogramming with potential in vivo therapeutic efficacy in PD-L1+ TNBC. To this end, we engineered
and pharmacologically optimized entolimod, a derivative of the natural TLR5 agonist Salmonella flagellin.
Importantly, three Phase I safety trials cumulatively involving nearly 200 subjects showed that systemically
administered entolimod is safe. Our recent work showed that entolimod suppresses metastatic PD-L1+ TNBC by
stimulating durable CD8+ T cell immunity. Here, we show that entolimod-driven PMN-MDSC reprogramming
governs the anti-metastatic activity of entolimod in PD-L1+ TNBC. These findings provided the rationale for our
additional studies showing that combining entolimod with α-PD-L1/Paclitaxel triggers regression of early-stage
mouse PD-L1+ TNBC and induces durable immunity. However, whether entolimod enhances the antitumor
activity of α-PD-L1/Abraxane in locally advanced and the neoadjuvant and/or adjuvant setting of metastatic PD-
L1+ TNBC, for which this therapy is FDA approved, remains unknown, as well as whether entolimod alters the
PMN-MDSC response as part of its mechanism of action. To test our central hypothesis, we propose two aims:
(1) to determine the most effective TNBC treatment platform and disease setting by which entolimod bolsters
the efficacy of α-PD-L1/Abraxane; and (2) to elucidate the contribution of PMN-MDSCs to the mechanism by
which entolimod promotes the antitumor efficacy of α-PD-L1/Abraxane in TNBC.

Public health relevance
PROJECT NARRATIVE FDA approval of anti-PD-L1/Abraxane in 2019 is the first-ever immunotherapy based treatment modality for PD- L1+ triple negative breast cancer (TNBC). Despite this advancement, overall response rates remain low and survival is extended by only a few months. This proposal seeks to further develop our clinical drug entolimod with anti-PD-L1/Abraxane in pre-clinical PD-L1+ TNBC mirroring the clinical paradigm of disease so that this effective immunotherapy platform can be translated to the clinic for this difficult-to-treat and deadly cancer.